Lab-to-User Training and Dissemination for the FEBio Software Suite

SUMMARY
Finite element analysis has become an indispensable tool for research and discovery in the biomedical sciences.
Historically, the lack of a software environment that was tailored to the needs of the field hampered research
progress, dissemination of research and sharing of models and results. Investigators previously relied on
commercial software, but these packages were not geared toward biological applications, were difficult to verify,
and precluded the easy addition, extension and sharing of new features. To address these issues, we developed
the FEBio software suite, a FE framework designed specifically for analysis in biomechanics and biophysics.
FEBio employs mixture theory to account for the multi-constituent nature of soft and hard tissues, unifying the
classical fields of irreversible thermodynamics, solid mechanics, fluid mechanics, mass transport, chemical
reactions and electrokinetics. Despite the popularity of the FEBio software suite, we have never been able to
fully address the needs of our user base in terms of dissemination and training. The overall aim of this project is
to develop an integrated software environment for FEBio to deliver new approaches for digital training and
dissemination to our user community. This will be accomplished through the following specific aims: 1) Create a
unified graphical software environment that encompasses the entire FEBio analysis pipeline. 2) Develop a model
sharing environment for FEbio. 3) Develop digital training materials and virtual training courses to serve and
expand the FEBio community. We will partner with laboratories that already use FEBio to evaluate these
advancements in training and dissemination. These new mechanisms for training and dissemination will improve
the accessibility of FEBio’s broad simulation capabilities, creating a larger, more collaborative user group that
spans a greater range of technical disciplines.

Public health relevance
PROJECT NARRATIVE This project will develop lab-to-user training and dissemination tools for the FEBio software suite. This software supports nearly 10,000 scientists in the fields of biomechanics, biophysics and biomedical engineering in general. The materials developed under this project will support the training of the next generation of biomedical simulation scientists in the areas of biomechanics and biophysics.